Social experience dependent modification of gene regulation and circuit function

SUMMARY:
Animals modulate their behaviors with social experience to increase fitness. The molecular and neural
circuit-based mechanisms underlying social experience-dependent behavioral modulation remains unclear.
Emerging evidence indicates the intimate connection among sensory experience, chromatin and behavioral
modifications. Defects in chromatin modulation are associated with many neuropsychiatric disorders.
Understanding the role of chromatin in regulating behaviors requires model systems with identified genes and
neural circuits with clear causal links to stereotyped behaviors. The Drosophila melanogaster is an excellent
model where these links were well elucidated for courtship behaviors. In D. melanogaster, Fruitless (Fru) and
Doublesex (Dsx) are master transcriptional regulators that control innate and learned sex-specific courtship
behaviors, respectively. fru is expressed in 2000 interconnected neurons marking courtship circuits. Socially
isolated wild type males show elevated courtship compared to grouped males. Conversely, socially isolated fruM
mutant males do not court, however, if grouped, they use olfaction to learn to court either males or females. This
learning requires the gene dsx, which is co-expressed with fru in decision-making neurons of courtship circuits.
How social experience regulates fru and dsx expression in the courtship circuits to modify circuit function remains
unknown. In published and preliminary data, we demonstrated that social experience and pheromone signaling
induces chromatin-based reprogramming of fru and dsx expression in the peripheral and central courtship
circuits. We also found that social cues change Fru target neuromodulatory gene expression in the peripheral
neurons, which alter neuronal sensitivity and circuit function. We hypothesize that detection of social signals
reprograms chromatin around behavioral switch genes such as Fru and Dsx in the central brain, which
in turn modulate circuit function and behaviors. To test this, we propose to identify social experience and
pheromone signaling-dependent changes in chromatin around fru and dsx genes, their effects on downstream
target gene expression, circuit function and behavioral outputs.

Public health relevance
HEALTH RELEVANCE: Results from the proposed study are expected to provide fundamental knowledge on the role of sensory experience-mediated changes in chromatin and gene expression in flexible behavior. The proposed experiments will identify basic epigenetic, molecular, and circuit principles by which the environment induces changes in gene expression to alter function of individual or ensemble of neurons within a circuit and ultimately modify organismal behaviors. Thus, our findings may lead to novel and cheaper sensory experience-based therapeutic strategies that harness similar types of plasticity against psychiatric disorders, such as autism spectrum disorders, depressive and anxiety disorders, where misprocessing of sensory information accentuates anxiety and social behaviors.